Human Disease and the Interplay Between Genes and the Environment

The University of Arizona (U of A) proposes the establishment of a Human Genes and the Environment Research (HuGER) Training Program. Development of the HuGER training program has been guided by several important realities. Most relevant to the HuGER TG is recognition of the fact that in the coming decades, a more precise determination of the influence of environmental exposures within a given genetic background on disease processes will be required to significantly improve pur ability to predict, detect, treat and monitor disease progression and disease response. In addition it is increasingly clear that epigenetic status will emerge as a critical process that is modulated by environmental exposures, leading to the adverse or beneficial manifestation of that exposure. The HuGER will build upon three inter-disciplinary pre-, and post-doctoral training programs integral to the creation of a successful multi-disciplinary training program that rains scientists in environmental genomics/genetics. An (i) NIEHS supported inter-disciplinary training Drogram in Toxicogenomics and Toxicology, an (ii) NSF Interdisciplinary Graduate Education and Research Training (IGERT) Program in Evolutionary, Functional, and Computational Genomics, and (iii) a Graduate nterdisciplinary Program (GIDP) in Statistics provide the foundation for the evolution of this multi-disciplinary nitiative. The HuGER curriculum has been created specifically to address the unique requirements of a multi-disciplinary training program, the cornerstone of which includes two new courses, redesigning additional courses, industrial research rotations, and an emphasis on the development of competent and effective communicators. This is especially important for the new generation of scientists who will need to communicate effectively across multi-disciplinary boundaries. The training environment at the U of A also Drovides trainees with access to appropriate contemporary computing and state-of-the-art technologies. The Training Program Faculty consist of a core of 17 scientists, from 10 departments, with active research programs in the areas of (i) the environmental and public health sciences and engineering, (ii) population and functional genomics/genetics, and (iii) computational biology and statistics/bioinformatics. Six principal units are participating in the HuGER Training Program: [1] the College of Agriculture and Life Sciences; [2 the College of Engineering; [3] the College of Medicine [4] the College of Pharmacy; [5] the College of Public Health; and [6] the College of Sciences. Five of these Colleges participate in the BIOS Institute which brings together scientists from disparate disciplines to solve complex biological problems. The Associate Director a this HuGER application, Dr. Vicki Chandler, is the Director of BIOS. To ensure the program is known for it multidisciplinary emphasis, it will be administratively housed within BIOS.